HIVAcute: rapid sample-to-result self-testing for HIV RNA

Abstract
Thirty percent of new HIV infections are transmitted by people unaware of their HIV status. Early detection of
the presence of infectious levels of HIV virus could support public health efforts to stop the spread of the virus.
The earliest biomarkers that can be used to diagnose HIV are elements of the HIV virion itself, including its
RNA genome. In order to increase accessibility to early HIV testing, this project will develop the HIVAcute, a
rapid self-test for the detection of HIV RNA based on isothermal RNA amplification that can be administered in
the home. This device will allow collection of a finger-stick blood sample, gain power from any USB port, and
deliver an automated diagnosis within 30 minutes. The work builds upon new developments in microfluidics
and paper-based diagnostics, expanding the range of human samples that can be prepared and tested at the
point of care. The long-term objective is to produce a commercial product for home testing. The specific aims
are: 1. Develop and validate point-of-care-compatible sample acquisition and preparation strategies that rapidly
deliver at least 25-125 copies of HIV RNA from a 50 µL finger-stick blood sample in a form that supports iSDA-
based detection. 2. Create and optimize isothermal real-time RT-iSDA assays for sensitive detection of HIV
RNA and controls. 3. Design and build prototypes of the MD-NAAT platform that incorporate the output of Aims
1 and 2 for home HIV testing. 4. Develop near-product sample-to-result HIVAcute prototype and validate the
prototype's user acceptability, ergonomics, and sensitivity as compared to laboratory standards. 5. Develop
HIVAlert, a modification of HIVAcute that could use self-administered swabs to detect HIV+ semen in the
vagina after unprotected sexual contact.

Public health relevance
Project Narrative Of the 11 million people currently living with HIV in the United States, a large number do not know their HIV status. As thirty percent of new HIV infections are transmitted by people unaware of their HIV status, early detection of the HIV virus could support public health efforts to stop the spread of the virus. This project will develop HIVAcute, a home test for HIV virus that will allow people to seek treatment for their disease earlier than any home test available today, and perhaps even prevent their becoming HIV positive in the first place.